Persistent HIV expression induced type I IFN responses and inflammaging

ABSTRACT
Despite effective anti-­retroviral therapy (cART), HIV-­infected individuals remain at an unusually high risk of
morbidity and mortality from HIV-­associated non-­AIDS (HANA) clinical conditions, such as cardiovascular
disease, neurocognitive decline, and osteoporosis. The excess risk for these age-­related diseases is attributed
to the residual immune activation that persists despite cART. Older cART-­suppressed HIV-­infected individuals
have an even greater risk for these inflammation-­driven diseases compared to younger counterparts;; this
suggests a synergistic adverse effect of HIV and advanced age. In our preliminary studies, we observed that
cART-­suppressed HIV+ individuals, especially those of older age (≥50), exhibited higher
monocyte/macrophage activation and had greater cell-­associated RNA levels (ca-­RNA) despite no significant
difference in reservoir size (HIV DNA), suggesting a link between HIV gene expression and monocyte
activation. Importantly, we found that de novo HIV unspliced viral RNA expression alone, even in the absence
of virus particle production, can induce production of type I IFN responses and pro-­inflammatory cytokines in
macrophages. In addition, we observed that HIV and aging appear to synergistically advance CD8+ T cell
exhaustion, as defined by increased expression of inhibitory receptors (IRs). Also, co-­culture of HIV-­infected
macrophages and CD8+ T cells revealed that increased IR expression is mediated, at least in part, by type I
IFNs. Collectively, these preliminary findings support our central hypothesis that the increased HIV unspliced
RNA expression in aged individuals drives type I IFN responses from infected monocytes/macrophages, which
in turn promotes CD8+ T cell exhaustion, causing a loss of virological control, and hence, perpetuating this
HANA-­inducing inflammatory cycle. In this study, we propose innovative approaches and sampling from a
prospective cohort of HIV-­infected individuals stratified by age and matched by duration of cART compared to
age-­matched uninfected individuals to test our hypothesis. In Aim 1 we will determine if expression of
unspliced HIV RNA in macrophages and ageing synergistically enhance type I IFN responses. In Aim 2 we will
determine how age, HIV, and monocyte/macrophage-­derived inflammatory responses drive CD8+ T cell
exhaustion. In Aim 3 we will evaluate how age and CD8+ T cell exhaustion contribute to the persistence and
expression of the viral reservoir. We predict that these studies will lead to the identification of the biological
mechanisms that drive HANA diseases despite effective cART. Such insight will be critically important for
development of effective strategies to decrease or reverse the persistent immune activation driving disease
pathogenesis in the growing population of older (≥50 years old) individuals living with HIV.

Public health relevance
PROJECT NARRATIVE In HIV- infected individuals immune activation and inflammation persist despite ART suppression, with many immunological defects similar to ones observed in the aged population. In this proposal, we will test the hypothesis that advancing age and HIV synergistically promote myeloid cell- induced type I IFN responses and CD8+ T cell exhaustion, resulting in greater residual HIV gene expression that acts as a persistent and potent stimulus of immune activation. Identifying the underlying mechanism driving age- associated diseases in HIV- infected individuals and specifically, probing the relationship between HIV persistence and chronic inflammation, is imperative to develop effective strategies to decrease or prevent this innate immune- driven accelerated aging process.